Administrative Core

Project Summary:
The Administrative Core for this Metabolic Basis of Disease (MBD) Phase 2 center will support the mentoring
and career development of the research project leaders (RPLs). In addition, the Administrative Core will be
responsible for overall leadership and management of the MBD Center. The primary effort will be focused on
facilitating mentorship and career development of the RPLs as well as coordinating the enhancement of our
scientific infrastructure. This approach will enable us to promote the biomedical research discoveries that
advance our understanding of the etiology and underlying causes of metabolic aspects of different disease
states. The MBD Center administration will be located on the second floor of the Basic Science Building where
the Center Director and administrative assistant are in very close proximity. In addition, all three of the RPLs
have laboratory space on this floor. The Center Director (Stephens), Associate Director (Morrison), the
Preclinical Core, the Molecular Mechanisms Core, and the RPLs are all housed in this building and this will
greatly facilitate communication and day-to-day interactions between all members. The Internal Advisory
Committee (IAC) will provide oversight of the goals and mission of the Center and assist in the evaluation of pilot
projects. The IAC will consist of eight faculty members who have substantial mentoring experience and/or
expertise in scientific core management and method development. The administrative core will also oversee the
coordination of a new Pilot and Feasibility Program as well as the scientific cores, the IAC, as well as virtual and
yearly on-site Advisory Committee (AC) meetings. The Administrative core will coordinate all aspects of the
center related to administration and communication.